Administrative Core

PROJECT SUMMARY/ABSTRACT
The Sidney Kimmel Comprehensive Cancer Center (SKCCC) Administration facilitates the SKCCC vision,
mission and goals by promoting and enhancing overall planning, management and organization through a full
range of administrative services. Administration provides support and guidance necessary to achieve and
maintain the highest standards of excellence in cancer research at the SKCCC. This is achieved by supporting
scientific activities, leveraging SKCCC resources, and bringing SKCCC science to the catchment area, the
state of Maryland and beyond. SKCCC Administration provides efficient and effective administrative support to
the SKCCC's Director, Senior Leaders, Research Program Leaders, Shared Resource (SR) Directors and
SKCCC members. Ms. Rosalie Russell (nee Wollett) has served as Associate Director for Administration for
research and academic activities at the SKCCC since 1997. She directly oversees a staff of 126, up from 76 in
2016. In fiscal year 2021, the SKCCC Administration is directly responsible for the management of $188.9
million and more than 862,400 ft2 of space. Administration coordinates all aspects of membership activities for
285 faculty members across five schools, encompassing 34 departments.
SKCCC Administration has accomplished many noteworthy achievements over this grant period. Major new
initiatives supported since the last renewal include: 1) facilitating development of the 2020–2025 SKCCC
Strategic Plan, Innovation for Impact 2025; 2) supporting the reorganization of the SKCCC Research
Programs; 3) developing the SKCCC Bloomberg~Kimmel Institute, funded by a $125 million gift for cancer
immunotherapy; 4) developing the SKCCC Cancer Convergence Institute, supported by a major institutional
investment of $20 million; 5) supporting the submission of grant applications that resulted in an increase of
direct peer-reviewed cancer-related research funding from $66.7 million to $78.5 million between 2015–2020;
6) providing comprehensive administrative support for submission of nine multicomponent grants (e.g., UG1,
UM1, U19, U54), resulting in six funded awards; 7) facilitating recruitment of 42 new Members; 8) supporting
the development of the Translational Research Central Services SR into a full SR in this application and
consolidating 15 SRs into twelve to better meet the needs of SKCCC Members; 9) supporting growth of the
Clinical Trials Office from 146 FTE to over 200 FTE to facilitate clinical research; 10) completing the planning
and occupancy of over 145,000 ft2 of space in the Skip Viragh Outpatient Cancer Building, which opened in
April 2018; 11) creating CCSGe, an electronic system for the CCSG submission and the Administrative
Business Center Tracking Portal for tracking of all research-related administrative service requests; 12)
deploying $25.0 million over five years for new project and pilot grant opportunities; and 13) promoting
research-relevant communication across the SKCCC catchment area through additional social media
platforms, cancer-focused symposia and development of the Community Outreach and Engagement website.